2023 Myogenesis GRC & GRS

ABSTRACT
This proposal requests partial support for an international meeting on Myogenesis as part of the Gordon
Research Conference (GRC) and Gordon Research Seminar (GRS) series to be held at the Renaissance
Tuscany Il Ciocco Resort Lucca (Barga), Italy June 11-16, 2023. The international meeting on GRC Myogenesis
has historically been viewed as one of the preeminent skeletal muscle meetings, attracting speakers and
attendants from around the world. The major goal of the 2023 Conference is to broaden our current knowledge
on emerging single cell technologies that are being used to understand how different cell types in the muscle
microenvironment contribute to muscle formation through development, and how this disease and aging affect
the ability of an organism to maintain a healthy muscle mass. Leaders in the field will present recent unpublished
data to educate conference attendees while stimulating interactive discussion amongst the group. Additional
program events, including poster sessions, specific social events and informal gatherings in the afternoons, will
ensure maximal level of interaction between established scientists and junior scientists/trainees. Thus, we expect
the 2023 Myogenesis GRC will provide an ideal scenario to stimulate new breakthroughs in muscle biology and
will benefit attendees at every professional level. We will convene invited speakers to the GRC to exchange new
information on the underlying mechanisms of cell signaling, altered metabolism and epigenetic mechanisms that
affect muscle formation. In addition, four evening poster sessions will stimulate interactions between all
attendees. We will provide education, networking opportunities, and career path mentoring to our junior scientists
through the GRS, a two-day conference program targeting graduate students and postdocs that takes place
immediately preceding the GRC. The GRS will conduct four sessions of talks and two poster sessions by
graduate students and postdoctoral fellows. Moreover, during the GRC, 4 sessions of "1-minute poster
presentation" will provide a forum for junior scientists to present their work and receive feedback from other
participants (approximately 50% of trainees will present in this forum). These activities represent a unique
opportunity for the next generation of scientists to highlight their research on myogenesis, interact with their
peers, and form new collaborations. Achieving these aims will place the field in a better position to accelerate
the advancement of muscle biology and thus the development of new therapies for muscle. Additional program
events, including poster sessions, poster teasing, specific social events and informal gatherings in the
afternoons, will ensure maximal level of interaction between established scientists and junior scientists/trainees.
The venue of the conference on the Il Ciocco Italy offers a relaxing atmosphere conducive to creative thinking
and the exchange of ideas that will benefit attendees at every professional level. Thus, we expect the 2023
Myogenesis Gordon Research Conference will provide both a stimulating program and an ideal setting for
attendees to advance their understanding of skeletal muscle biology.

Public health relevance
Project Narrative The 2023 Myogenesis Gordon Research Conference entitled “Building, Maintaining, and Regenerating Muscle” will bring together expert speakers to educate and exchange information on the latest conceptual advances in skeletal muscle research. Topics to be covered include Building and maintaining skeletal muscle, Satellite cells and regeneration, The complexity of skeletal muscle architecture, Extrinsic regulation of the muscle microenvironment, Intrinsic signaling in muscle cells, Epigenetic, transcriptional, and post-transcriptional regulation of myogenesis, Cellular and molecular mechanisms of muscular diseases. The health relatedness of this application comes from the information disseminated by our speakers which will be used to advance our understanding of mechanisms regulating muscle health.